Immune Signatures and Clinical Outcomes in Acute Pancreatitis

PROJECT SUMMARY/Abstract
Acute pancreatitis (AP) accounts for over 300,000 admissions in the U.S. with annual costs exceeding $3
billion. Most cases of AP are mild (MAP) with a hospital stay of 3-4 days, but approximately 15% of AP
subjects develop severe disease (SAP), defined by presence of persistent organ failure. Up to a third of SAP
patients expire from multi-system organ failure after weeks in the intensive care unit. To date, no therapeutic
agents have been successful at ameliorating the protracted hospital course of SAP. The National Institute of
Diabetes and Digestive and Kidney Diseases workshops identified two critical knowledge gaps as barriers to
developing pharmacologic interventions: 1) the establishment of a highly accurate, early prediction tool to
identify which subjects will develop SAP during hospitalization; 2) a more in-depth knowledge of SAP
mechanistic pathways and immuno-pathogenesis to identify novel therapeutic targets.
We propose the MoSAIC Study (iMmune SIgnAtures and ClIniCal outcomes in AP), a prospective multi-
center, observational cohort that will address both of these knowledge gaps in SAP. We recently discovered
a novel multi-cytokine panel (angiopoetin-2, hepatocyte growth factor, interleukin-8, resistin, and tumor
necrosis factor-α receptor-1) that accurately predicts SAP early in the disease process with an accuracy of
0.89 and significantly outperforms existing prediction tools. Aim 1 of this project is to validate the multi-cytokine
panel in a large, ethnically diverse AP population across multiple U.S. clinical sites.
In preliminary studies, immunologists at the Benaroya Research Institute (BRI) have identified unique immune
cell changes such as an increase in monocytes and a decrease of T follicular helper and memory B cells in
blood samples of AP patients compared to healthy controls. In Aim 2, the MoSAIC study will extend this work
by defining the circulating immune cells that correspond with cytokine signatures in early AP and identifying the
immune pathways driving the development of SAP. This will generate the first high-dimensional phenotypic
analysis of immune cell types in human AP and provide new insights into its immune mechanisms.
MoSAIC investigators have NIH-funded complementary expertise in pancreatitis and immunology. The
team is led by well-published pancreatologists at the Ohio State University and immunologists at BRI,
supported by a dedicated bioinformatics core at BRI. It also includes three additional academic medical centers
with proven track-records of enrolling ethnically diverse populations into prospective AP research trials.
Successful completion of the MoSAIC study will have the following impact by: 1) establishing an
accurate, early prediction tool for SAP, 2) providing groundbreaking insight into the early immune events of
SAP based on robust human data, 3) identifying therapeutic immune targets for further testing, and 4)
establishing a U.S. multicenter research platform for launching clinical trials to test immunotherapies in AP.

Public health relevance
NARRRATIVE Acute pancreatitis is a common gastrointestinal disease that can rapidly progress to life-threatening severe pancreatitis (SAP). We propose the MoSAIC study to better understand the mechanisms of SAP and develop a blood test that identifies which patients will progress to SAP during hospitalization.